Administrative Core

Project Summary/Abstract-Adminstrative Core
The overall objective of the Administrative Core of the George M. O'Brien Kidney Center at Yale is to ensure
that Center functions and activities are optimized to fulfill the overarching goal of facilitating basic, translational
and clinical research that will advance the prevention and treatment of kidney diseases. To achieve this
objective, the Administrative Core will pursue the following specific aims:
1. Provide central oversight and financial management of the Center
2. Organize and coordinate activities of all administrative committees
3. Monitor core use and services, and allocate resources among Center cores
4. Facilitate communication with kidney research community including maintenance of Center website
5. Manage Pilot and Feasibility Grant Program
6. Monitor and allocate resources to Enrichment Program